Project 1: Utilization, Quality, Selection and Prices in MA Going Forward

PROJECT SUMMARY/ABSTRACT Even with the advent of Accountable Care Organizations (ACOs), for the foreseeable future the Medicare Advantage (MA) program is likely to remain numerically the most important alternative to Traditional Medicare (TM). Although MA currently enrolls over a quarter of Medicare beneficiaries, the reimbursement reductions ushered in by the ACA could diminish the array of supplemental benefits offered to MA beneficiaries, increase premium and cost sharing levels, and decrease the willingness of both beneficiaries and plans to participate. Moreover, many of these changes could also affect selection, the management of care, and prices private MA plans negotiate with health care providers with repercussions for the entire delivery system. Given the prominence of MA in the Medicare program, evaluating these critical aspects of MA in light of these policy changes represents an important opportunity for research. In addition, despite substantial new and important contributions by our team to the understanding of current risk adjustment methods in addressing risk selection, their adequacy in the face of the ACA's payment cuts remains an open question. This project continues our study of the provision of services, selection, and the quality of care under MA and how all of those change over time as new policies are implemented. By continuing the complementary stock and flow comparisons of health risks in the MA and TM populations that we have employed using both administrative and survey data, we will clarify how payment changes affect the performance of MA and TM. Furthermore, through the incorporation of data from Truven MarketScan as well as from several additional health plans that serve this market, we will be able to examine for the first time pricing MA plans obtain from providers and examine how those prices change over time and relate to market-level factors such as provider concentration. In short, in our current Program project we have developed methods to address the salient policy issues that MA poses, we have addressed them at a time when reimbursement was becoming more generous and MA was expanding, and now we can apply our methods to a more austere reimbursement policy in which successful ACOs may nonetheless decide to convert to MA plans.